Hibernation--a New Approach To Stroke Therapy

Postischemic progression of brain damage is multifactorial. We are analyzing a state in which nature has solved this complex problem. Hibernation with its metabolic, hematologic and cell membrane adjustments permits animals to withstand extremely low blood flow in the brain for protracted periods with no cell loss. Efforts to isolate and identify the mechanisms that regulate the controlled metabolic depression and tolerance of profound brain ischemia that forms the essence of natural hibernation are in progress. In hippocampal slices, hibernation confers robust resistance to hypoxia and glucose deprivation as compared to slices from non-hibernating ground squirrels and rats at 37 degrees C, 20 degrees C and 7 degrees C. These findings indicate that hibernation involves tolerance to an in vitro form of ischemic stress that is not strictly dependent on temperature. Protein synthesis (PS) in hippocampal slices is greatly depressed at the same incubation temperatures. PS in vivo was below the limit of autoradiographic detection in brain sections, and in brain extracts was determined to be 0.04% of the average rate from active squirrels. Further, it was threefold reduced in cell-free extracts from hibernating brain at 37 degrees C, eliminating hypothermia as the only cause for protein synthesis inhibition. PS suppression involved blocks of initiation and elongation and its onset coincided with the entrance phase of the hibernation bout. An increased monosome peak with moderate ribosomal disaggregation in polysome profiles and the greatly increased phosphorylation of eIF2a are both consistent with an initiation block in hibernators. The elongation block was demonstrated by a threefold increase in ribosomal mean transit times in cell-free extracts from hibernators. Phosphorylation of eEF2 is increased, eEF2 kinase activity is increased and protein phosphatase 2A activity is decreased during hibernation which contribute to the elongation block. No abnormalities of ribosomal function or mRNA levels were detected. These findings implicate suppression of PS as a component of the regulated shutdown of cellular function that permits hibernating ground squirrels to tolerate "trickle" blood flow and reduced substrate and oxygen availability. Further study of the factors that control these phenomena may lead to identification of the molecular mechanisms that regulate this state. We have observed phase separation of lipids in cellular membranes in a variety of cells during hibernation. Cholesterol and high-freezing point lipids are segregated into gel-phase domains. Proteins are laterally displaced from these rigidified domains into the more fluid regions of the membrane that are enriched with low-freezing point lipids. When the animal arouses, and the temperature elevates, the gel-phase domains melt and the normal lipid distribution is restored. These changes seem to form a membrane fluidity buffer and participate in the cellular mechanism of temperature acclimation. Arylalkylamine-N-acetyltransferase (AA-NAT) is the rate limiting enzyme for synthesizing melatonin. The AA-NAT gene is one of the few specific genes upregulated in hibernation and its elevated expression in the suprachiasmatic nucleus and the medial habenular nucleus suggests that melatonin may play a role in the maintenance of hibernation. Dephosphorylation of Akt/PKB has been found to occur in multiple tissues during hibernation and FoxO1 has been found to translocate from cytoplasm to the nucleus and bind to its consensus sites on DNA by electrophoretic mobility shift analysis. This resembles the signal transduction program that regulates development of the dauer larva phase in C. elegans. Constructs that express signal transduction molecules with the post-translational modifications observed in hibernation are being transfected into cell lines and tested for cytoprotective effects in oxygen/glucose deprivation studies. We have found marked SUMOylation of proteins during hibernation and are studying the potential contributions of this post translational modification to cytoprotection.